Predicting and Preventing Acute Respiratory Distress Syndrome after Hematopoietic Stem Cell Transplantation

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem cell transplantation (HSCT) offers an advanced treatment option for conditions that are
otherwise incurable. Pulmonary complications are common following HSCT and severely compromise its
overall success rate. The most severe end of this spectrum is acute respiratory distress syndrome (ARDS),
which occurs in 5% of patients following HSCT, with a mortality >60%. As effective treatments for ARDS are
lacking, developing new ways to prevent ARDS is likely to be more successful in improving patient outcomes.
Two critical knowledge gaps make developing successful prevention strategies difficult: 1) an inability to
reliably identify high-risk patients before ARDS has developed and; 2) an incomplete understanding of the
mechanisms and subtypes of post-HSCT ARDS. The scientific objectives of this application are to address
these critical knowledge gaps through the following Specific Aims:
1) Develop and validate a risk-prediction model incorporating pre-transplant, post-transplant and in-
hospital risk factors that can help identify which patients are most likely to develop post-HSCT ARDS.
2) Prospectively evaluate metabolomics in patients at high-risk of developing post-HSCT ARDS and utilize
clinical, biomarker and metabolomics data to explore endophenotypes of post-HSCT ARDS.
Aim 1 leverages highly innovative data extraction techniques to develop a real-time continuous ARDS risk
surveillance system for patients who undergo HSCT. Aim 2 evaluates the role of metabolomics, an emerging
analytic tool, in advancing mechanistic understanding of why patients develop post-HSCT ARDS, as well as
whether recently described ARDS endophenotypes can be identified post-HSCT ARDS.
The applicant’s long-term goals are to: 1) become an independent translational clinician-scientist leading a
multidisciplinary research team focused on improving outcomes of patients who develop respiratory
complications after HSCT, and 2) develop effective strategies to prevent post-HSCT ARDS, one of the most
significant post-transplant complications today. The training goals of the applicant are to develop advanced
skills in statistics, biomedical modeling, machine learning, and metabolomics to facilitate these long-term goals.
To address these training needs, the applicant has constructed a comprehensive career development plan that
includes targeted didactic opportunities in the areas of training need above, with additional “hands-on”
experience in all of these areas. The mentorship team and research environment is uniquely well suited to the
applicant’s needs, combining expertise in critical care informatics and metabolomics at a high-volume
academic transplant center. The proposal supports the NIH mission by striving to improve outcomes of patients
who develop respiratory failure after transplantation, while training a junior investigator in the essential skills
necessary for his transition to research independence.

Public health relevance
PROJECT NARRATIVE Respiratory complications after stem cell transplantation remain unacceptably common and are associated with substantial patient suffering, healthcare utilization, and mortality. In this proposal, we explore how best to predict which patients develop Acute Respiratory Distress Syndrome (ARDS) – one of the most severe forms of respiratory failure – after transplant and use these clinical prediction tools to better study the mechanism of ARDS development through a novel analytic technique (metabolomics). We will then combine clinical and metabolomics data to help identify subgroups of patients who may benefit from targeted preventative interventions, the implementation of which will be the goal of future projects.